Role played by Acid Ion Sensing Channels in Peripheral Artery Disease

PROJECT SUMMARY/ABSTRACT
A reflex arising from contracting hind limb skeletal muscles is an important neural mechanism that is
responsible for causing the cardiovascular adjustments to exercise. These adjustments, which include
increases in peripheral vascular resistance, cardiac contractility and rate, function to increase arterial blood
flow and oxygen to the exercising muscles, and in turn support their ability to contract. This neural mechanism
has been named the exercise pressor reflex and its afferent arm is comprised of group III and IV fibers whose
endings are located in and near the muscle interstitium. In patients with peripheral artery disease (PAD) the
exercise pressor reflex is exaggerated. The overall goal of the experiments proposed in this application is to
shed light on the role played by lactic acid in evoking the exercise pressor reflex in both health and simulated
peripheral artery disease. The proposed experiments will pay particular attention to Acid Sensing Ion Channels
(ASIC) and will focus on the role that they play in evoking the exaggerated exercise pressor reflex in PAD.
Lactic acid, produced by contracting skeletal muscles is believed to stimulate group III and IV afferents,
signaling the spinal cord and brainstem that the arterial blood supply to working muscle is not meeting its
metabolic demand. In the proposed experiments, we will pay particular attention to two important ASIC
isoforms, namely ASIC1a and ASIC3. We will examine in decerebrated unanesthetized rats the responses to
contraction of group III and IV muscle afferents both before and after either pharmacological blockade of the
above receptors or after they have been “knocked down” with siRNA. The proposed experiments will also
examine the responses to contraction of these afferents before and after knockdown of myophosphorylase in
the triceps surae muscles. In addition the responses of group III and IV afferents to contraction in mutant rats
whose ASIC3 has been functionally inactivated by CRISPR Cas 9 technology will be determined. The
proposed experiments will be performed both in rats with freely perfused femoral arteries and in rats with
femoral arteries that have been ligated for 72 hours before the start of the experiment. The latter preparation
simulates the arterial blood flow patterns seen in patients with PAD and therefore serves as a useful animal
model of this disease. The proposed experiments are anticipated to provide new information about metabolic
factors that cause the exercise pressor reflex to be exaggerated in PAD.

Public health relevance
PROJECT NARRATIVE Exercise is well known to stimulate thin fiber sensory nerves in contracting muscles. Stimulation of these nerves reflexively activates the sympathetic nervous system, an effect which causes vasoconstriction in the heart, kidneys and the skeletal muscles. In hearts whose coronary arteries are narrowed by disease, this vasoconstriction can cause chest pain and fatal arrhythmias. Likewise, in muscles, whose arteries are narrowed by disease, this vasoconstriction can cause muscle ischemia and result in pain that is only relieved by the cessation of exercise (i.e., intermittent claudication). Over time, the exaggerated pressor responses to exercise in patients whose arteries perfusing the vascular of the legs can result in thickening of the walls of the heart, which is maladaptive, and irregular heart rhythms, some of which are not compatible with life.